AGTC: Attaining Genomics Talent Cloud through Undergraduate Research Education

ABSTRACT
An inclusive and diverse workforce in genomics is much needed as it could alleviate disparity in
genomics data inclusion and genomics-enabled medicine. However, recruitment and retention of
underrepresented minority in genomics research and the biomedicine workforce are confronted by
special challenges from lack of exposure, opportunities, and insufficient resources. In addition,
undergraduate ethnic minorities and disadvantaged groups face extra barriers that prevent them
entering this fast-growing, deep-reaching biomedical field. This AGTC (Attaining Genomics Talent Cloud)
through Undergraduate Research Experience Program addresses the barriers and challenges to a more
diverse workforce by capitalizing on the long-term collaboration and geographic proximity of two higher
education institutions: Tennessee State University (a minority serving institution) and Vanderbilt
University Medical Center (a top tier research intensive institution), providing two-year-long intensive
basic training with intermingled research activities in genetics and genomics, and a full summer (10
week) of mentored research experience. Undergraduate student participants will be recruited from
Tennessee State University, in four cohorts, and they will be immersed in a genomic sciences education
and research environment, trained through a focused curriculum, and mentored by successful
researchers at Vanderbilt University Medical Center and Tennessee State University, surrounded by peer
mentors and role models. The AGTC Program uses established supporting networks and high impact,
best practice to ensure each minoritized participant’s success and persistence in genomics and pursuit
of biomedical career.

Public health relevance
Minorities and disadvantaged populations are significantly underrepresented in genomics and biomedical research professions. The AGTC (Attaining Genomics Talent Cloud) through Undergraduate Research Experience Program, a joint proposal from Tennessee State University and Vanderbilt University Medical Center, seeks to address this underrepresentation through excellent didactic training, mentoring and near-peer mentoring by Tennessee State University and Vanderbilt faculty and students, and a rich research experience at Vanderbilt. The outcome of project is that trainees will persist in genomics and biomedical research and contribute to workforce diversity.